Protein Aggregation and Neurotransmitter Deficits in Parkinson Disease

Project Summary/Abstract
Parkinson disease (PD) is the second most common neurodegenerative disorder and causes a
combination of motor, cognitive, and psychiatric symptoms. The clinical manifestations of PD
are highly variable, and the underlying neurobiological mechanisms that drive this variability
remain unknown. Dementia in PD is associated with neocortical accumulation of alpha-
synuclein in Lewy bodies, which likely contributes to impaired function of cortical neurons.
However, PD also affects a number of subcortical nuclei including noradrenergic (NA) neurons,
which have diffuse projections to cortical and limbic regions. Thus impaired function and
degeneration of both cortical neurons and subcortical NA neurons may contribute to nonmotor
symptoms in PD, including dementia.
We hypothesize that levels of synaptic and noradrenergic proteins in cerebrospinal fluid
(CSF) are lower in PD. The loss of cortical synaptic terminals and cortical noradrenergic
neurons in PD brain tissue would likely correspond to reduced levels of cerebrospinal fluid
(CSF) analytes derived from cortical synapses and noradrenergic neurons. Thus, such CSF
analytes would be useful as biomarkers reflecting either disease progression or
therapeutic targets and have the potential to act as indicators for the effectiveness of
disease-modifying therapies. Our preliminary data from cross-sectional analysis of CSF and
post-mortem brain tissue samples supports our strategy to utilize these CSF analytes as
indicators of PD disease progression.
The primary objective of the proposed study will determine whether CSF analytes derived from
cortical synaptic terminals (aim 1) and noradrenergic neurons (aim 2) differ between PD and
control participants and whether levels change longitudinally as disease progresses. We will use
both traditional and single-molecule immunoassays and liquid chromatography to quantitate
CSF analytes of interest. The second objective is to determine whether levels of the CSF
analytes correlate to motor, cognitive, and psychiatric features of PD (aim 3). The final objective
for the candidate is to continue authoring manuscripts and generate preliminary data towards a
K23 application, where the candidate would continue to develop and validate CSF biomarkers.
Although with independent aims, the present study leverages existing data collected as a part of
multiple large-scale longitudinal studies with established funding. Scientifically, we envision a
combination of CSF biomarkers that may be used to track the progression of motor, cognitive,
and psychiatric symptoms in Parkinson disease. These CSF biomarkers will provide information
on disease prognosis and can be used to monitor the effectiveness of novel disease-modifying
therapeutics.

Public health relevance
Project Narrative This supplement project will develop methods to measure specific protein components in the cerebrospinal fluid of people with Parkinson disease (PD), and determine whether these measurements correlate with the development of cognitive impairment and other symptoms that occur with disease progression. These types of biomarker measurements are needed to guide the development of treatments for PD. The supplement project will also support the career development of an investigator developing expertise in biomarkers for PD.